Bioenergetics and Neuronal Network Remodeling in a Rodent Model of Temporal Lobe Epilepsy

Epilepsy affects 3 million adults and 450,000 children in the US. One-third of chronic epilepsy is
intractable to current antiseizure medications. Temporal lobe epilepsy (TLE), the most frequent form of acquired
epilepsy, is typically initiated by brain injury, such as status epilepticus (SE), followed by a latent period wherein
molecular and cellular remodeling occurs leading to chronic epilepsy. The process of remodeling is poorly
understood. Not every patient who experiences episodic SE will progress to TLE, and the latent period of
epileptogenesis can vary from weeks to years. There is a critical need for new mechanistic understanding and
early recognition of post-SE TLE for risk stratification and better management.
Mitochondrial dysfunction is increasingly recognized as an inciting factor for TLE, not only acutely after
SE, but also contributing to epileptogenesis for refractory TLE. However, there are major knowledge gaps in
disease thresholds and a lack of sensitive in vivo tools to detect and monitor the subclinical epileptogenesis
process for early intervention before epilepsy is established. Our long-term goal is to understand the remodeling
process that leads from SE to TLE. As an important step towards this, we are now in a strong position to test the
HYPOTHESIS that a novel 4D oxy-wavelet MRI can be a proxy to detect foci with mitochondrial dysfunctions in
post-SE injury that can contribute to TLE development. The focus of the current proposal is to validate and
establish 4D oxy-wavelet MRI as a biomarker for identifying brain foci with mitochondrial dysfunctions. We will
first validate 4D oxy-wavelet MRI as a non-invasive, region-specific means of monitoring mitochondrial function
in the brain. We will use the well-known mitochondrial drugs, rotenone and 2,4-dinitrophenol, to
pharmacologically impair or enhance mitochondrial respiration, respectively. Then we will monitor spatiotemporal
evolution of region-specific changes in mitochondrial functions with 4D oxy-wavelet MRI in a post-SE TLE rat
model. The 4D oxy-wavelet MRI signal will be correlated with ex vivo mitochondrial functional assays, including
Oroboros respirometry, and brain metabolic profiling with in vivo MR spectroscopy.
Our study will validate 4D oxy-wavelet MRI as a non-invasive method for monitoring mitochondrial activity
in the brain. Using a rat model of post-SE TLE, we will use the new MRI tool to observe temporal and region-
specific changes of mitochondrial function. These data can advance use of the 4D oxy-wavelet MRI as a non-
invasive biomarker for predicting post-SE TLE. As this method is non-invasive, it can be translated to clinical
setting in the future.

Public health relevance
One-third of chronic epilepsy is intractable to current antiseizure medications, including the temporal lobe epilepsy initiated by status epilepticus followed by a latent period wherein molecular and cellular remodeling process leading to chronic epilepsy is poorly understood. There is a lack of sensitive in vivo tools to detect and monitor the subclinical epileptogenesis process for risk stratification and early intervention before epilepsy is established. Our study will establish a novel 4D oxy-wavelet MRI as a non-invasive means for monitoring spatiotemporal evolution of mitochondrial dysfunction, a key player of epileptogenesis.